EFFECT OF CHRONIC INFECTION CONDITIONS ON THE SET OF MTA

Dr. Jim Morgan is currently in the Dentist Scientist program at The University of Iowa College of Dentistry. He is progressing in his clinical specialty of Oral & Maxillofacial Surgery. Dr. Morgan is in the introductory phase of his research. Dr. Morgan attended the Annual IADR meeting in Vancouver, BC, March 10-14, 1999.